BIOCHEMICAL MEDIATORS OF PREECLAMPSIA

To investigate possible abnormalities of NO/NOS system including the various modulators of NOS in hypertensive disease during pregnancy. Additionally the contribution of neurosteroids to altered baroreceptor activity will be determined in preeclamptic and normal pregnancies by measuring plasma neurosteroid levels in these two groups.